Neuroimaging Core

Project Summary
Neuroimaging Core
Core B provides equipment, technical support and training for a wide variety of neuroimaging modalities,
including fMRI/DTI, high-density EEG, fNIRS, multifocal ERG, and Adaptive Optics, as well as a range of
screening tools for visual and cognitive assessments and workstations for imaging data analysis. Most of the
equipment is housed in the Neuroimaging Core space in the Neuroscience COBRE suite in the Department of
Psychology, adjacent to the labs of the 12 cognitive neuroscience faculty who are the primary users. The fMRI
facility is a contractual partnership with our community hospital (Renown Health) and includes excellent long-
term access and low cost for research scanning at both of their MRI facilities. The core supports a large user-
base and a number of active grants, as well as several of the Center’s previous and current projects and pilot
projects. It provides unique resources at the university that are essential to the research programs of all of our
cognitive neuroscience faculty as well as additional users. In Phase III we will continue to expand and
strengthen these services including supporting the Pilot Project Program and the broader neuroscience
community, and will develop the business plan and recharge mechanisms that will transition the core to a
permanent user- and institution-supported facility by the end of the COBRE funding.

Public health relevance
Project Narrative Neuroimaging Core The Neuroimaging core enables and enhances the scope and quality of the research of past, current and future COBRE projects, and other investigators with the goal of providing access and support to advanced neuroimaging technologies. The core will continue to provide essential research infrastructure to allow understanding of neuronal mechanisms at different scales of processing in both healthy brain function and neural deficits.